Core B: Developmental

Abstract: RUSTBELT CFAR Developmental Core B Revision
Hispanic/Latinx people are disproportionately affected by HIV: In 2021, according to the
Centers for Disease Control, Hispanic/Latinx persons made up 18% of the population of the United
States but accounted for 29% of new HIV diagnoses. Hispanic/Latinx men who have sex with men
(MSM) accounted for 33% of diagnoses among all MSM. In Puerto Rico (PR), there are currently
15,801 people living with HIV. San Juan, the capital of PR, is a Phase 1 Priority Jurisdiction identified in the
Ending the HIV Epidemic (EHE) Initiative. Latinx people in PR have an estimated lifetime risk for HIV
infection of 2.08% (1 in 48), higher than the lifetime risk for HIV diagnosis among Latinx people in the
continental United States (1.92%;1 in 52). Furthermore, the estimated HIV prevalence in the general adult
population in PR is nearly 1.1%, and 7.3% among sexual minority men. PR also has one of the highest
levels of HIV status unawareness among sexual minority men, and the lowest pre-exposure prophylaxis
uptake reported in the United States. Greater diversity in the healthcare workforce is an important strategy to
address racial and ethnic healthcare disparities. The Rustbelt CFAR proposed to develop education and training
pathways for Puerto Rican students to become scientists or physician-scientists engaged in HIV/AIDS research.
The Rustbelt Investigators for the Next Generation (RING) Program was first developed and funded in
2022/23 in response to the NIH supplement request for CFAR Diversity, Equity, and Inclusion Pathway Initiatives
(CDEIPI). The objectives of the RING Program are (a) to provide a 10-week summer mentored research-training
experience in HIV/AIDS for 10 undergraduate and/or masters students from the University of PR (UPR) at Case
Western Reserve University (CWRU) or the University of Pittsburgh (Pitt); (b) to provide career development
activities, including weekly seminars led by outstanding faculty leaders and training in techniques in the Rustbelt
CFAR laboratories and core facilities that lead to research careers in HIV; and (c) to evaluate the scholars’
attitudes about engaging in a research career in HIV before and after participation in the RING Program. The
goal of the new Rustbelt CFAR-PREP is to enhance the pool of PR students who complete PhD degrees in
HIV/AIDS. Considerations driving the development of the Rustbelt CFAR PREP included: (a) while research
opportunities exist in the UPR system, they often lack the depth, breadth and rigor of those on the mainland,
leaving students under-prepared for graduate school; and (b) many UPR students already take “gap” years to
prepare for graduate school, but are pressured into and distracted by part-time employment for financial reasons.
We will recruit students from UPR campuses in Rίo Piedras (a populous district of San Juan), Mayagüez, Cayey,
Humacao, and the Medical Sciences campus in San Juan for the RING and CFAR-PREP programs. The third
program in this continuous pipeline of student researchers in HIV is to develop and implement the Rustbelt
CFAR/UPR PhD Training Program for graduate students engaged in HIV research at the UPR Medical
Sciences Campus. The Rustbelt CFAR is committed to developing scientists in PR that have the expertise to
address the local HIV epidemic.